Prediction of suicide death using EHR and polygenic risk scores

ABSTRACT
Suicide death is at epidemic levels in the US, but remains extremely difficult to predict and prevent. For
individuals with evident suicidality, <10% die by suicide; accurate prediction of who makes up this 10% is not
currently possible. For the ~50% of suicide deaths with no prior evidence of suicidality, prediction is even more
elusive. Effective prevention will involve more work to accurately identify and characterize subsets at specific
risk of mortality. Our research program, the Utah Suicide Mortality Risk Study (USMRS) has unique resources
to address these knowledge gaps, including unprecedented demographic, clinical, genetic, geocoding for
urban/rural and other spatial studies, and exposure data from the world’s largest genetically-informative,
population-ascertained cohort of suicide deaths. Currently, >12,000 suicide deaths are linked to statewide
electronic health records; >7,200 of these suicides have genotyping for computation of polygenic scores, and
>1,000 have whole genome sequencing, enabling discovery of more rare risk-associated changes in gene
pathways. Clinical and demographic comparisons are made to 10:1 population-matched data, and genetic data
can also be compared to samples from population-ascertained deaths where cause of death was not suicide
(>34,000 with health data and biosamples for DNA). Studies in our previous award period engaged in
developing and using a natural language processing (NLP) algorithm to more accurately define suicide deaths
with vs. without prior nonfatal suicidality. This NLP greatly increased the specificity of detection of suicidality,
yielding far more precisely defined groups. These groups demonstrated strikingly significant clinical differences
driven in part by significant differences in underlying polygenic liability such that the SD-S group showed highly
increased risk of a broad range of psychopathology in both clinical and polygenic data, but SD-N group had
low clinical co-occurring psychopathology and greatly attenuated polygenic risk of psychopathology. In this
renewal, it is critical that we extend these findings to refine the characteristics of these broad, fascinatingly
different groups of suicide deaths that span psychiatric and physical health. We will double our sample sizes
and will use data elements including clinical data, extended familial risks, environmental factors, polygenic
scores, and targeted gene pathways to ascertain and characterize groups where risks lead specifically to
mortality. We will use knowledge of group differences to ascertain and characterize more precise subgroups of
suicide mortality. Our previous work also identified clusters of diagnoses with putative protective associations
with suicide behaviors and death. We will characterize these clusters to determine factors associated with
resilience. Finally, we will pursue additional external replications of our results in the Mount Sinai Medical
School BioME data and in the large PsychEMERGE Consortium.

Public health relevance
NARRATIVE We will continue work to define and characterize subgroups at high risk of suicide mortality using electronic health records (EHR), demographics, environmental exposures, familial risks, and genetic differences in a large cohort of suicide deaths. Results will help understand which 10% of those with evidence of suicidality may go on to die by suicide, and will help begin to understand risks among those with no prior evidence of suicidality, where prediction and treatment is particularly elusive. Comparisons will be made to Utah population controls and replication will be done in data from the Mount Sinai BioME repository and the PsychEMERGE Consortium.